Investigating the Ability of Human Blood Neutrophils to Kill Cancer

Abstract
Neutrophils are not often considered as cancer killing immune cells in the same way that natural killer cells,
cytotoxic T cells and macrophages. However, the inherent capability of neutrophils to be cytotoxic is clinically
evident in diseases of hyperinflammation (such as sepsis) where activated neutrophils contribute to organ failure
by destroying otherwise healthy cells and tissues. Therefore, neutrophils possess all the cytolytic machinery
needed to be destructive to host tissues and we propose that includes cancer. What is lacking is a clearly defined
targeting mechanism that can focus the cytotoxic potential of neutrophils towards cancer cells in a specific and
controlled manner. This proposal will present published and preliminary evidence that neutrophils can indeed
be successfully targeted to cancer cells leading to a newly described non-apoptotic cancer killing mechanism
called trogoptosis. Trogoptosis (Greek: trogo; “gnaw”) is a newly described effector mechanism that brings
neutrophils into the discussion of tumor killing immune cells. Trogoptosis is a form of antibody-dependent cellular
cytotoxicity (ADCC) that triggers neutrophils to destroy antibody-opsonized tumor targets by forming a transient
receptor-mediated synapse between the neutrophil and the tumor target. Killing occurs as a result of the
neutrophil gnawing at the tumor plasma membrane and dismembering it into chunks, and is distinct from
apoptosis and necrosis. Neutrophils internalize these pieces of tumor cells by phagocytosis and migrate away.
Trogoptosis is dependent on the neutrophil beta2 integrin Complement Receptor 3 (CR3; CD11b/CD18; Mac-1).
Antibody blockade of CR3, or neutrophils from families with genetic absence of CR3, obviate trogoptosis. Given
the relative recency of this discovery, there remains much to be learned about this effector mechanism.
A highly selected experimental plan is offered to fit within the budget and timeframe of an R03 yet allow
rigorous testing of the hypothesis that neutrophil trogoptosis is a function that can be enhanced by agonists of
neutrophil CR3 and augment the efficacy of anti-cancer antibody therapy. This R03 would develop a nascent
collaboration between two laboratories with a track record in the use of biomimetic experimental systems to
study breast cancer invasion and the function of human neutrophils. The experimental approach will use fibrous
gels of varying stiffnesses and ECM composition that reflect differences that exist among various bodily tissues
and organs. MDA-231 TNBC will be modeled as single invasive cells (Specific Aim 1) and as 3D spheroids
(Specific Aim 2) in testing the trogoptoptic killing by human neutrophils introduced as tumoricidal effector cells.
Additional work will determine if neutrophil CR3 is a druggable target that can enhance the effectiveness of
neutrophil-dependent tumor killing and thereby potentially serve as an adjuvant to anti-tumor antibody therapy
in the clinic. Our overall objective is to demonstrate that human neutrophils can be stimulated to function
effectively and specifically as tumoricidal immune cells.

Public health relevance
Project Narrative Neutrophils are the first line of defense against infection and exhibit a unique cell-killing mechanism called trogoptosis (“gnawing”), based on successive puncturing of cancer cell membranes. We investigate the efficacy of this mechanism in the context of different tumor cell surface markers as well as the extracellular matrix. We envision that neutrophil trogoptosis can be therapeutically enhanced for anti-tumor activity in combination with adjuvant drug therapy.